Chemistry and Biology of Alkyl Phosphotriester Lesions

ABSTRACT
The human genome is continuously attacked by a variety of endogenous and exogenous genotoxic agents,
which can lead to DNA damage and compromise genomic integrity. Alkylating species constitute a ubiquitous
class of DNA damaging agents. Aside from forming nucleobase adducts, alkylating agents can also attack one
of the non-carbon-bonded oxygen atoms of internucleotide phosphate group to yield backbone alkylation
products, i.e. the alkyl phosphotriester (alkyl-PTE) lesions. Although the alkyl-PTE lesions are induced at
relatively high frequencies, very little is known about their repair and biological consequences. We hypothesize
that unrepaired alkyl-PTE lesions may lead to the development of cancer and other human diseases by
compromising the flow of genetic information through inhibiting DNA replication and transcription, and inducing
mutations in cells. We also posit that the effects of the alkyl-PTE lesions on DNA replication and transcription
may be modulated by the size of the alkyl group conjugated with the backbone phosphate in DNA. Moreover,
alkylating agents are among the earliest and most widely prescribed cancer chemotherapeutic agents. Hence,
a systematic investigation about how the alkyl-PTE lesions perturb DNA replication and transcription will reveal
molecular insights about how exposure to alkylating agents contributes to cancer development, and provide an
important knowledge basis for designing better cancer chemotherapeutic agents. To test the above hypothesis,
we propose experiments according to three specific aims: Aim #1. To synthesize oligodeoxyribonucleotides
(ODNs) harboring site-specifically inserted alkyl-PTE lesions with different flanking sequences; Aim #2. To
investigate how the alkyl-PTE lesions perturb the efficiency and fidelity of DNA replication in cells. Aim #3. to
examine the transcriptional mutagenesis and repair of alkyl-PTE lesions. The proposed research is built upon
our established expertise in the chemical syntheses of lesion-carrying ODNs and in utilizing shuttle vector
methods for the assessment about how DNA lesions perturb DNA replication and transcription in cells. The
outcome of the proposed studies will provide a systematic and molecule-level understanding about the repair
and human health consequences of the alkyl-PTE lesions. Thus, the proposed research will lead to important
knowledge for assessing the risk of human exposure toward alkylating agents, for understanding the roles of
these lesions in the etiology of human diseases, and for developing better strategies for cancer chemotherapy.

Public health relevance
PROJECT NARRATIVE The major objective of this application is to understand the repair and human health consequences of a unique group of DNA alkylation products, alkyl-phosphotriester lesions. The outcome of the proposed research will improve our understanding about the implications of alkylated DNA lesions in the etiology of human cancer development and may provide important knowledge basis for developing better cancer chemotherapy.